ASSESSMENT AND IMPROVEMENT SERVICE FOR THE NICHD WEBSITE

The Federal Consulting Group team will collaborate with the NICHD web team in performing website assessment and improvement services using the American Customer Satisfaction Index (ACSI) methodology. These services shall include use of an econometric model based on the ACSI and customized for the designated website. This model shall include relevant elements that drive customer satisfaction, satisfaction itself, and desirable customer behaviors. To obtain data for processing by the model, the FCG team shall work closely with NICHD in conducting an on-line survey with multiple, model-related questions for the selected website elements, satisfaction, and future behaviors. In addition, the survey shall include customized questions developed by NICHD that are not related to the model but desirable for informational purposes and general analysis. These questions may be deleted, modified, or replaced at appropriate intervals during the subscription period.